Pharmaceutical Nanofactories: Intracellular synthesis of bioactive drug molecules

Project Summary:
Since the discovery of anticancer and chemotherapeutic pharmaceuticals, society has been challenged
by detrimental and life altering side effects, drug resistance via cellular mutations, and distributed non-
metabolized pharmaceuticals back into the environment, which has long-term effects on wildlife and
water supplies. The synthetic control my team has on the pore environment of mesoporous silica
nanoparticles (MSN) offers a unique perspective of delivering active, heterogenous catalytic species to
cells. Using the vast knowledge base already known on internalizing MSN via endocytosis for drug
delivery, we will design biocompatible porous nanomaterials that will enter cells with inorganic and
biological catalysts entrapped inside the pores. Protected molecules that are not biologically active will
become activated once they encounter the catalytic active sites. The confined space offered by the
mesopores will protect the catalytic species (tethered molecular catalysts and exogenous enzymes) from
the reductive environment of the cells. We can selectively functionalize the external and internal pore
environments, allowing us to control the internalization and stabilization intracellularly along with catalytic
properties. Current technology to deliver biologically active molecules contains numerous disadvantages
the site-specific synthesis could eliminate. The scientific innovation includes a systematic investigation
of novel porous, biomaterials entrapping metal catalysts and enzymes to investigate the synthesis and
activation of prodrug and profluorophore molecules intracellularly. The hypothesis is that if catalysts
can be supported and protected in the pore structure of MSN and the nanomaterial will be
internalized by cells, then bioorthogonal chemical reactions can be conducted intracellularly to
produce biologically active molecules on site eliminating the need for delivery of drug molecules
that have detrimental side effects and lead to resistance.
The teaching innovation of this project is in the cooperative and team-oriented research activities
involving participants from high school through the PI. Students will receive hands-on training on
numerous state-of-the-art instrumentations along with chemical syntheses, characterization, and
biochemical techniques. This research will also be used to guide weekly undergraduate biochemistry
laboratory experiments, focused on important interactions between biomolecules and inorganic
substrates for enzyme stabilization and as part of the curriculum in lecture courses. The impact to
students is first-hand experience in working cooperatively and essential skills that go into scientific
research and understanding, such as the importance of proper controls, statistical analysis, and
communication skills that are required in science and engineering.

Public health relevance
Narrative: Intracellular bioorthogonal chemical synthesis of biologically active molecules can be advanced if the catalytic active materials can be protected from the reductive environment of cells. Biocompatible, structured, and multifunctional 3D porous silica nanomaterials are ideal to fundamentally investigate metal complex and enzymatic catalyzed activation of bio-active molecules intracellularly.